Novel assays for assessing protein-protein interactions in Alzheimer's disease

Abstract Cell-based assays more closely mimic biology than direct inhibition studies. Therefore, drug discovery companies are increasingly utilizing cellular screening assays. Current reporter systems are unable to reliably measure in-cell transient protein-protein interactions. Furthermore, many are based upon split enzyme systems, which require long incubation steps, are not real-time and are typically low throughput. In order to improve on these existing technologies, we will develop a split SUMOstar system engineered to contain a tetracysteine recognition motif for a biarsenical-based fluorophores. There are several advantages for using split a SUMOstar fluorescent reporter system, including relatively small fusions (~6 Kda) to the target proteins of interest, lower non-specific interaction with native proteins and the ability to take real-time measurements in high-throughput applications. Furthermore, using structural based mutagenesis, we can engineer the kinetics and binding affinity of the split SUMO interaction, allowing us to fine-tune the reporter assay to measure transient protein-protein interactions.

Public health relevance
Transient protein-protein interactions are key to understanding cellular processes in neurological disease states. Currently, these interactions are poorly understood in a cellular environment. We propose to build a detection system for monitoring transient protein-protein interactions in cells. This will allow high throughput drug screening against new targets and enable novel research of neurological disease state pathways.